Project 4: Impact of cardiovascular disease on proliferation and genetic diversity of hematopoietic stem cells

During aging, descendants of individual hematopoietic stem cell (HSC) clones can begin dominating significant
portions of the peripheral blood, a phenomenon called clonal hematopoiesis (CH). CH has recently been
shown to correlate with an increased risk for CVD. The mechanisms behind this association are only beginning
to be explored. Existing studies have focused on examining how driver genes that are frequently mutated in
CH affect the inflammatory phenotype of peripheral immune cells that drive CVD. Here, we propose to
investigate the possibility of reverse causality. We will study how CVD influences HSC evolution and CH
emergence, using mathematical modeling and novel experimental methods. In aim 1, we will construct a
mathematical model of somatic HSC evolution in steady state and CVD. Myocardial infarction has been shown
to double the proliferation rate of HSCs. Furthermore, our unpublished preliminary data, collected in
collaboration with other PPG projects, show that atherosclerosis can similarly increase the proliferation of
HSCs by up to 2.5-fold. We hypothesize that chronically elevated proliferation in the HSC compartment
accelerates CH due to neutral drift and/or due to accelerated emergence of clones with a selective advantage.
To test these hypotheses, we will construct a stochastic branching process model of genetic diversity in the
HSC population over a human lifetime. We will begin by studying neutral drift alone and will then carefully
expand our model to include the occurrence of beneficial mutations. Results from this aim will elucidate the
role of HSC proliferation in CH emergence and provide a firm quantitative basis for future research into the
mechanisms of CH. In aim 2, we will investigate experimentally whether CVD causes clonal hematopoiesis in
mice. We will establish murine models of CH and test our hypothesis that increased HSC proliferation rates
caused by CVD enhance CH. We will use polyguanine genotyping, a genetic analysis that relies on non-coding,
hypermutable DNA repeats which rapidly accumulate insertion/deletion mutations, to measure with high
sensitivity whether clonal expansions occur in the blood of aging mice. We will then determine whether the
incidence of CH is significantly increased in two CVD models (atherosclerosis and myocardial infarction). In
Aim 2B, we will study CVD and CH in a transplantation setting. We will isolate and transduce highly purified
LT-HSC populations with a lentivirus carrying a library of genetic barcodes, along with a collection of seven
fluorescent proteins that can be used to track clonal dynamics in vivo. We will then transplant tagged HSCs
into myeloablated hosts, titrating their numbers such that CH emerges within a relatively short time frame.
Finally, we will induce myocardial infarction and atherosclerosis and score the incidence of CH in comparison
to age-matched controls. In conjunction with our in silico approach in aim 1, we anticipate that these
experiments will provide fundamental insights into how HSC population dynamics are influenced by CVD.

Public health relevance
During aging, descendants of individual hematopoietic stem cell clones can begin dominating significant portions of the peripheral blood, a phenomenon called clonal hematopoiesis. Clonal hematopoiesis has recently been shown to correlate with an increased risk for cardiovascular disease. Here, we propose to develop mathematical and experimental models for determining whether increased stem cell proliferation associated with cardiovascular disease accelerates the emergence of clonal hematopoiesis.